Administration

PROJECT SUMMARY (See instructions); The administrative support of UWCCC provides the focal point for achieving

Public health relevance
RELEVANCE (See instructions); UWCCC Administration provides the support necessary for the UWCCC to achieve its mission in the forthcoming five years. The three highest goals of the UWCCC are: 1) to conduct the highest quality research into the origins and control of cancer; 2) to translate these research findings to evaluation in the clinic through well designed clinical trials with corresponding biologic endpoints whenever possible; and 3) to provide the best care possible to all cancer patients by carefully integrating high quality cutting edge care with clinical research in a compassionate and individualized manner.